Sample Multiplexing as a Key Enabling Technology for Quantitative Proteomics

Summary: Sample multiplexing as a key enabling technology for quantitative proteomics
Proteins are the biological effector molecules in cells and tissues—the molecules which carry out most
catalytic, structural, and regulatory functions inside cells. Their rates of synthesis and degradation (and thus
their abundance levels) are often controlled post-transcriptionally. Furthermore, the activities of proteins are
frequently modulated by post-translational modifications (e.g., phosphorylation and ubiquitylation) and depend
on other macromolecules, including DNA, RNA and proteins to interpret modifications and initiate new,
condition-specific activities. Over 20 years of genomics and proteomics research has not succeeded in a
general solution to the grand challenge of assigning function to the ~20,000 human genes. This reflects not
only the magnitude of the challenge, but the lack of technologies that can be i) adapted to handle the
throughput that complex experimental designs demand and ii) used to discover selective pharmacological
tools to perturb and reveal a protein's function. In this R35 proposal, we address these two important research
priorities in the field of proteomics.
Mass spectrometry (MS)-based proteomics has evolved into an essential tool, allowing for both qualitative and
quantitative analyses of biological systems. During the past 24 years, my lab has pioneered many approaches
to study protein phosphorylation and ubiquitylation as well as directly profiling cell-state-specific protein
expression differences by MS. In addition, our contributions to the sample multiplexing (isobaric tagging) field
over the past 14 years are vast. Our current tandem mass tag (TMT) workflow supports up to 18 samples for
simultaneous proteome-wide analysis. While sample multiplexing clearly increases throughput by more than
an order of magnitude, in proteomics, there are other nonobvious key advantages. For example, an 18plex
dataset acts as a remarkable closed system creating an N proteins x 18 conditions matrix with essentially no
missing values, facilitating powerful statistical analyses. In addition, very complex experimental designs can
be accommodated within the 18 samples to include biological replicates, time series, dose-response, rescue,
positive and negative controls, etc. Thus, sample multiplexing in proteomics can arguably be thought of as the
world's most powerful biological assay, accurately measuring the levels of up to 10,000 proteins across 18
conditions in less than one day. Over the next several years, we will improve isobaric tagging-based proteome
analysis even more by i) increasing the multiplexing capacity to 35plex, ii) creating custom software to manage
the entire proteome analysis in real time, iii) designing targeted sample multiplexing workflows for ultra-high
throughput, and iv) creating and applying novel chemoproteomic workflows to identify chemical probes to
illuminate protein function in an unbiased manner.

Public health relevance
Assigning mechanistic function to the ~20,000 human genes is an intense research area with great promise for the improvement of human health. In addition to a gene's role in normal physiology, context-dependent malfunctions in a gene product's function are commonly implicated as contributing factors in the causation of many illnesses as diverse as diabetes, cancer, and Alzheimer's disease. This proposal will develop new mass spectrometry-based technologies for sample multiplexing specifically tailored to chemical biology workflows to define small molecule-protein interactions which can be used as precursors for therapeutic interventions. 0